MECHANICAL LOAD EFFECT ON CARDIAC EXCITATION-CONTRACTION COUPLING

ABSTRACT
The heart must adjust its contractile force to counteract the blood pressure changes (due to physical activity,
body position, emotional stress, etc.) to maintain cardiac output. Cardiac muscle cells possess the intrinsic
ability to sense mechanical load and fine-tune contractile force accordingly. Previous work by us and others
found that increasing mechanical loading on muscle strips or single myocytes results in an increase of the
cytosolic Ca2+ transient (CaT) that increases the contractile force to partially compensate for the added
mechanical load. A sustained increase in CaT requires augmenting the Ca2+ content of the sarcoplasmic
reticulum (SR), which must come from a net increase of Ca2+ across the sarcolemma. However, the
mechanism that links mechanical loading to the control of Ca2+ entry remains unknown. Plausible mechanisms
for this net increase include a mechanical load-induced increase of Ca2+ influx through L-type Ca2+ channels
(ICaL) or a decreased efflux from Na+-Ca2+ exchanger (INCX). However, studying how mechanical loading affects
ICaL or INCX has been hampered by the technical difficulty of subjecting myocytes to mechanical loads while
simultaneously doing patch-clamp experiments. Now we have overcome this obstacle. Innovation: Recently
we invented the Patch-Clamp-in-Gel technique that enables us to simultaneously measure membrane voltage
or current, SR or cytosolic Ca2+, and contraction in single myocytes embedded in a viscoelastic hydrogel that
controls mechanical load on the cell. Preliminary data reveal that mechanical load increases ICaL, prolongs the
action potential (AP), and increases SR Ca2+ content in rabbit ventricular myocytes. Therefore we hypothesize
that mechanical load increases Ca2+ entry during AP to elevate the SR Ca2+ content and Ca2+ release that
increases CaT, which can partially compensate for increased mechanical load. While a compensatory
increase in CaT might be beneficial to offset moderate increases in mechanical loading, we further posit that
excessive loading causes SR Ca2+ overload by excessive ICaL increase or INCX decrease, leading to
arrhythmogenic spontaneous Ca2+ release. Failing hearts cannot generate enough force to maintain adequate
cardiac output. We hypothesize that the compensatory increase of CaT with increased load is blunted in HF.
Our interdisciplinary team will develop the new Patch-Clamp-in-Gel technique and test the hypotheses
using ventricular myocytes from healthy and HF rabbit, and transgenic mouse to achieving three specific aims.
(1) Systematically investigate how mechanical load regulates myocyte E-C- coupling during cardiac cycle. (2)
Decipher mechano-electro-transduction effects on ICaL and INCX and Ca2+ entry during AP. (3) Understand how
pathological high load may cause Ca2+ dysregulation and arrhythmogenic activities in HF. The outcome of this
project will elucidate how mechanical load affects cardiac excitation-contraction coupling in compensatory
response to physiological loading, and how mechanotransduction is impaired in heart failure patients to cause
arrhythmias and contractile dysfunction.

Public health relevance
NARATIVE In every heartbeat the cardiac muscle contracts against a mechanical load to pump blood. Excessive loading such as in chronic high blood pressure can cause cardiac dysfunction and heart diseases. The proposed research will develop innovative state-of-the-art `Patch-Clamp-in- Gel' technology to investigate the cellular and molecular mechanisms underlying mechanical stress induced cardiac arrhythmias and heart failure. Having this information is important because it will provide the base for developing new strategies to treat many types of heart disease associated with mechanical stress.